Project 6 - Molecular regulation of sympathetic neuron activity in cardiovascular disease

Project summary/abstract
Heart failure (HF) is major cause of morbidity and mortality and its incidence is expected to increase over the
next decade. Characteristics of HF include an imbalance in the autonomic nervous system, with increased
sympathetic tone and parasympathetic withdrawal, as well as chronic inflammation. Factors that contribute to
increased sympathetic tone include increased release of the primary neurotransmitter norepinephrine (NE) and
co-transmitter, neuropeptide Y (NPY). Although b-blocker therapy is a well-established approach for modulating
the effects of NE during heart failure, even high levels of these agents do not fully prevent the effects of
sympathetic activation. Recent work has demonstrated that increased plasma levels of NPY are correlated with
worse outcomes in HF, including increased sudden cardiac deaths, suggesting that the co-release of NPY
contributes to disease pathology and may be arrhythmogenic. Indeed, addition of an NPY blocker together with
b-blocker therapy has shown promise in preventing the effects of increased sympathetic activation. Despite
evidence that overactivity of sympathetic neurons contributes to HF, the mechanisms underlying the enhanced
release of NPY have yet to be investigated. Importantly, direct observations of NPY transport in sympathetic
neurons and knowledge of the molecular pathways involved are lacking. We hypothesize that inflammatory
signals that are elevated during cardiovascular disease potentiate NPY trafficking and release, contributing to
disease progression. Although treatments can help stabilize or slow disease progression for patients with heart
failure, prognosis remains poor with a 5-year survival rate of approximately 50%. Thus, understanding the
molecular changes that underly the dynamic regulation of sympathetic neurons will enable the development of
novel therapeutic interventions. We recently developed a novel imaging technique, optical pulse-chase axonal
long-distance (OPAL) imaging, that enables the visualization of axonal trafficking of proteins with single-molecule
resolution. Using this and other imaging techniques, we propose to investigate the trafficking of NPY-containing
vesicles in cardiac sympathetic neurons from neonatal mice cultured in compartmentalized microfluidic
chambers. We will investigate the molecular motors and trafficking machinery involved in the long-distance
axonal transport of NPY, including Rab-GTPases and kinesin motors. Elucidation of this pathway will provide
targets of opportunity for therapeutic interventions for conditions such as HF. Additionally, we propose to
investigate the dynamic regulation of NPY trafficking and release in response to inflammatory cytokines found
in HF. Together, these will provide the first report of dynamic regulation of vesicular trafficking and neuropeptide
release in sympathetic neurons, and could transform how we detect and treat some cardiovascular diseases.

Public health relevance
Project Narrative The sympathetic nervous system, the “fight of flight” branch of the autonomic nervous system, plays a key role in modulating cardiac output. Sympathetic overactivity during disease states such as heart failure contributes to disease pathology; however, the molecular mechanisms that contribute to this overactivity are largely unknown. In this project we propose to use high-resolution single-molecule imaging techniques to investigate the dynamic regulation of sympathetic neurons on a molecular level as an avenue to develop novel therapeutic interventions.